Optimization of a novel antimicrobial for pulmonary delivery to fight respiratory infections

Title: Optimization of a novel antimicrobial for pulmonary delivery to fight respiratory infections
Antibiotic resistance (AR) has reached alarming levels in the US and other parts of the world in recent decades.
Increased infections with AR bacterial pathogens result in increased healthcare costs and a decline in positive
clinical outcomes. Enterococcus faecium, Staphylococcus aureus, Klebsiella pneumoniae, Acinetobacter
baumannii, Pseudomonas aeruginosa, and Enterobacter species together are known as ESKAPE pathogens
because they are the six top-priority dangerous ‘superbugs’ easily generate resistance and require the most
urgent attention for novel antibiotics. Multidrug-resistant (MDR) ESKAPE infections are emerging causes of AR
infections associated with high morbidity and mortality rates. Despite tremendous efforts, the lack of efficacious
new antimicrobials is an enormous concern because of the potential threats posed by emerging/re-emerging AR
pathogens to public health and global healthcare. It’s a significant medical challenge to lack novel, effective
antibiotics to treat AR bacterial infections, and our long-term objective is to develop novel antimicrobials to
combat urgent AR bacterial infections efficiently. We have recently developed a natural airway host defense
molecule SPLUNC1 inspired lead antimicrobial peptide, A4-X7, that has enhanced stability, potency, and safety,
making it an ideal therapeutic candidate for treating a broad range of AR bacterial respiratory infections. In this
application, we hypothesize that formulating A4-X7 for aerosolized pulmonary delivery is an effective and well-
tolerated novel approach to successfully treating AR bacterial respiratory infections. Our proposed studies will
prepare, characterize, and evaluate the antimicrobial and antibiofilm activities of formulated A4-X7 for
aerosolized pulmonary delivery. We will then determine aerosol dispersion performance, lung deposition,
pharmacokinetics, pharmacodynamics, and inhalation aerosol safety as liquid aerosols and inhaled dry powders
of formulated A4-X7. By focusing on developing novel A4-X7 for targeted pulmonary delivery, our study will
provide an alternative and effective treatment to fight MDR ESKAPE respiratory infections.

Public health relevance
Relevance to Public Health Concerns Multi-drug resistant (MDR) bacterial infections are becoming an emerging threat to human health and, by 2050, are expected to be responsible for over 10 Million deaths per year. We have discovered and optimized a promising new therapy to overcome MDR bacterial infections. The successful development of a formulated new, potent, safe therapeutic for pulmonary delivery will provide a transformative approach to combat a broad spectrum of MDR bacterial respiratory infections.